Clinical Research Support Services for NIEHS Contract Task Order 8 - Staffing

The purpose of this severable Task Order is to provide staffing support in the areas of protocol support and patient care.